ILC2s Polarize Microglia to a Reparative, M2-Like Phenotype

Project Summary: Stroke is the fifth leading cause of death in the United States, predominantly affecting aged
people. FDA approved treatments are proving inadequate as many patients are ineligible for reperfusion
therapies and they fail to treat secondary brain injury or help in brain repair. One of the most promising therapies
for stroke is targeting the peripheral and central nervous system immune responses that have modulatory roles
during all stages of stroke pathobiology. Aging affects immunologic responses by a global suppression of the
immune system, including dysregulation of cytokine mediators, leading to increased inflammation throughout all
systems, termed inflammaging. However, understanding mechanisms of healthy aging can bypass this effect.
Two candidate immune cells (1) microglia, brain-resident macrophages, and (2) innate lymphoid cells, a newly
discovered innate immune cell, may control pre- and post-stroke responses in the aged brain. Microglia
immunosurveil the brain during homeostasis and are quickly primed once injury is detected. Unfortunately, they
are affected by inflammaging causing them to be poor at anti-inflammatory responses, especially after brain
injury. Group 2 innate lymphoid cells (ILC2s) are a prime candidate in regulating microglial responses as they
produce anti-inflammatory cytokines (IL-4, IL-5, and IL-13) during times of injury. These cytokines modulate
microglia to a reparative phenotype by increasing their trophic and phagocytic capacity through upregulation of
healing proteins like heme oxygenase 1, arginase 1, and vascular endothelial growth factor alpha. The
communication between macrophages and ILC2s have been investigated peripherally in kidney ischemic-
reperfusion injury, but very little brain and in aging. Preliminary data show that with age, ILC2s increase in the
brain of male and female mice compared to other ILC types. Moreover, males have a multi-fold global increase
of total ILC and ILC2 counts putting their total ILC and ILC2 counts greater than females. Also, male ILC2s
produce more cytokines and have a greater anti-inflammatory capacity in aging than females. Lastly, young ILC2
soluble factors increase Nrf2 and Nrf2-regulated genes in microglia in vitro. This would suggest that aged ILC2s
could be beneficial in microglia polarization during inflammatory responses. Therefore, I hypothesize that ILC2s
are the brain’s gatekeepers of microglia polarization to a reparative, M2-like phenotype under: (1) homeostatic
conditions, (2) ischemic insult, and (3) with aging. In Aim 1, I will investigate the transcriptome of ILC2s and ILC2
soluble factors on microglia polarization. In Aim 2, I will identify the response of ILC2s to oxygen-glucose
deprivation, an in vitro model of ischemic injury, and how their soluble factors polarize primed microglia. Lastly,
in Aim 3, I will perform a “proof-of-concept” experiment to inquire the role of ex-vivo stimulated ILC2s on aged
microglia via adoptive cell transfer using intracortical injections of GFP+ ILC2s. Taken together, I will have
defined the capacity of ILC2 soluble factors to polarize microglia to a reparative phenotype. This will provide the
rationale to further explore ILC2 as a possible therapeutic platform in stroke and other neurologic disorders.

Public health relevance
Project Narrative The greatest risk factor for stroke is aging, which leads to a global dysregulation of pro-inflammatory responses throughout the body. Group 2 innate lymphoid cells (ILC2s) are anti-inflammatory, homeostatic mediators that have a role in the polarization of macrophages and other myeloid cells; ILC2s have not been investigated in models of stroke or extensively in aging. I will determine if ILC2 soluble factors mediate microglia polarization to a reparative, anti-inflammatory phenotype in aging and stroke models to better understand the role of ILC2s in aging neuroinflammatory responses.